Understanding the Impact of Digital Health Literacy and Health Supporters on Technology Use for Self-Management among Adults with Type 2 Diabetes

PROJECT SUMMARY/ABSTRACT
Day-to-day self-management by adults with type 2 diabetes is essential to avoid diabetes complications, yet
successful self-management behaviors remain difficult for many to achieve and sustain. Adults with diabetes
have rapidly evolving ways to track their behaviors, and the glucose levels their behaviors impact, but despite
having more information, people with diabetes still find it challenging to use their information to make healthy
behavior changes. The MPower Hub platform leverages evidence-based behavior change techniques,
including Self-Determination Theory-based personal data visualizations to increase autonomous motivation for
change, and Self-Regulation Theory-based goal setting and action planning, to empower adults with diabetes
with the information and support needed to achieve healthy diabetes self-management behaviors. MPower
Hub is a web-based platform that integrates rich real-time data from commercially-available continuous
glucose and activity monitors with patient-reported data about medication taking and other self-management
behaviors. MPower Hub prompts patients to choose behavioral goals based on their insights from interactive
visualizations of their information, then make action plans to reach their goals. This project is designed to
respond to the NI DDK PAS 23-086 call for "Small R01" pilot trials. The goal of this project is to optimize the
MPower Hub intervention protocol for adults with type 2 diabetes in preparation for a future multi-site efficacy
trial. First, the ability of the MPower Hub intervention protocol to support diabetes self-management will be
optimized via iterative enhancements, with 12 adults with diabetes who will use the platform for two months
each. Then, MPower Hub trial protocol feasibility will be assessed by randomizing 80 adults with type 2
diabetes and glycemic levels above clinical goals to MPower Hub, continuous glucose monitor alone, or activity
monitor alone for four months. Mixed quantitative and qualitative assessments will examine recruitment,
engagement, and retention metrics and feedback. Changes in self-management behaviors and glycemic levels
will be compared between arms. Successful completion of this project will produce a theoretically-grounded,
rigorously pilot-tested self-management intervention optimized for a fully-powered clinical efficacy trial. MPower
Hub is uniquely designed to produce new knowledge about how evidence-based behavior change techniques
can be integrated with data from increasingly available wearable monitors to empower healthy behavior
change. Results of this study will directly inform a future multi-site clinical efficacy trial, with the long-term goal
to produce inclusive and scalable tools to effectively improve diabetes self-management, increase the ability of
adults with diabetes to reach treatment goals, and reduce risks for diabetes complications.

Public health relevance
PROJECT NARRATIVE Over 30 million adults in the U.S. have type 2 diabetes, which can result in devastating complications such as strokes, kidney failure, and amputation if not well-managed. Day-to-day self-management by adults with type 2 diabetes, including glucose monitoring, taking medications, and healthy habits, is essential to avoid diabetes complications, yet, despite the rapidly expanding availability of wearable glucose and activity monitors, successful self-management remains challenging for many. This research aims to develop and test an approach to help adults use their personal diabetes information from wearable devices to achieve and sustain healthy diabetes self-management, which will reduce diabetes complications, and improve health and quality of life for people with type 2 diabetes.